Precision Medicine Center for Cystic Fibrosis

PROJECT SUMMARY/ABSTRACT (CELLS, TISSUES, AND MODELS CORE – CORE 4)
The Cells, Tissues, and Models Core (CTMC; Core 4) was established to provide well-differentiated epithelial
models for studies on the pathophysiology of cystic fibrosis (CF) and for molecular and gene therapy
experiments. The mission of the CTMC is to advance CF research within the scope of the National Institute of
Diabetes and Digestive and Kidney Diseases (NIDDK). CF affects multiple organs, resulting in digestive diseases,
liver diseases, nutritional disorders, diabetes, and lung disease These disorders affect people’s health and quality
of life. The Core achieves this mission by providing relevant models and technical expertise to investigators,
developing new in vitro models and approaches, training investigators, and attracting new investigators to CF
research and aiding in their development. The goals of the CTMC are to collect, process and maintain a human
tissue biobank of gallbladder, intestine, pancreas, vas deferens, kidney, and lung specimens, in collaboration
with the Clinical Phenotyping Core (Core 3). We will also generate in vitro models of these same organs from
humans, pigs, ferrets, and mice with and without CF. The Core will also characterize models and native epithelia
in collaboration with other Cores and investigators and perform bioelectric analyses, morphological evaluation,
gene expression profiling, and pH measurements in surface and luminal liquid. Finally, the Core will teach
investigators at the University of Iowa and other institutions how to successfully implement the methods for in
vitro model systems.